Resolving Relationships: Determining the Impacts of Environmental Matrices on the Ionization Efficiencies of Per and Polyfluoroalkyl Substances (PFAS) for the Development of a Semi-Quantitation Model

Abstract:
A number of analytical challenges hinder the accurate identification and quantification of
per and polyfluoroalkyl substances (PFAS) in the environment. These challenges include the lack
of reference materials for PFAS as well as the ionization variability due to matrix interferences in
electrospray ionization. In this externship, I plan on addressing these challenges by evaluating
major matrix characteristics of environmental water samples and their relationship to the ionization
efficiency. The observed relationships will be used to develop a preliminary statistical model for
the semi-quantitation of PFAS without reference materials. Through collaboration with the United
States Environmental Protection Agency, I will gain expertise from mentors, Dr. Sobus and Dr.
McCord, in using cheminformatics for solving analytical problems. The semi-quantitation model
developed as a result of the externship can be used to quantify transformation products of PFAS
degradation studies, such as the nano bio-remediation techniques designed under the parent NIH
grant, R01ES032717.

Public health relevance
Per- and polyfluoroalkyl substances (PFASs) are persistent and bioaccumulative chemicals that can cause adverse human health effects (ex. various cancers, endocrine disrpution). The relationship between environmental matrix coextracts and the ionization efficiency of electrospray ionization for various per and polyfluoroalkyl substances (PFAS) will be characterized as a result of this proposal. The observed relationships can then be utilized as correction factors within a semi-quantitation model for PFAS without reference materials. This model will be beneficial for the evaluation of PFAS degradation efforts by allowing the quantification of PFAS degradation products, but to date, no semi-quantitation models consider the impacts of matrix coextracts on ionization.